Tele-Health Extension for Phase 3 Parkinson's Disease Trial Cohorts

Abstract
Disease modification is the primary unmet need in Parkinson's disease (PD) therapeutics. Currently clinical
trials of promising candidate neuroprotectants are limited by the inefficiency and imprecision of repeated in-
person clinical assessments required of people with Parkinson's who volunteer to participate in these studies.
Emerging telemedicine and smartphone-based remote sensor assessments provide opportunities to help
overcome these obstacles and improve prospects for the success of future trials. Demonstrating the utility of
these relatively inexpensive accessible tele-health platforms for the measurement of PD progression would
also establish infrastructure for long-term follow up of participants after completion of interventional studies.
STEADY-PD3 and SURE-PD3 are active NINDS-funded phase 3 trials of potential disease-modifying
interventions in PD. Both studies, comprising ~600 early PD subjects, include biomarker sub-studies collecting
DNA and serial plasma samples and in a subset serial dopamine transporter (DAT) neuroimaging data that will
become part of the Parkinson's Disease Biomarker Program (PDBP). The objective of this proposal is to
leverage modern technology to develop, pilot and implement a 100% virtual model for long-term follow up
utilizing telemedicine and smartphone platforms for quantitative monitoring of clinician- and patient-reported
outcomes. Specific Aim (SA) 1 is to establish infrastructure for longitudinal remote follow up of phase 3 trial
cohorts; a) transitioning from site-based to a centralized coordination center to manage all subject activity, b)
conducting an annual telemedicine research visit (tele-visit) program, and c) implementing a smartphone data
collection platform tailored to a clinical trial cohort. SA2 is to compare smartphone (patient-driven) vs tele-visit
(clinician-driven) outcomes by a) correlating these platforms' component and composite features, and their
changes over years, and b) comparing their abilities to i) measure PD progression; ii) distinguish rapid vs slow
progressors based on baseline motor scale scores, DAT deficit or serum urate levels; and iii) demonstrate
persistence of any effects of isradipine or inosine in their respective trials. SA3 is to explore novel smartphone-
based real-life mobility biomarkers of PD disability and its progression that are normally inaccessible with
traditional office measures. The ability of passively collected smartphone data, on ambulation and location, to
enable assessments of physical activity and socialization that meaningfully integrate motor and non-motor
functions will be investigated. This project leverages the major phase 3 trial investments of NIH and study
subjects by extending their follow up to establish the utility of tele-health metrics for tracking PD progression in
clinical cohorts. Its results are expected to accelerate effective testing of a greater number of promising
candidates for disease modification. The results will have an immediate impact on the rational selection of
smartphone versus tele-visit monitoring in designing the next generation of PD trials, and may help identify and
substantiate novel digital as well as molecular biomarkers of PD.

Public health relevance
PROJECT NARRATIVE Clinical trials to find therapy that prevents worsening of Parkinson's disease have been hindered by the requirement of study subjects to repeatedly visit a research doctor's office for in-person testing over years. This project will investigate novel strategies for measuring the progressive disability of Parkinson's disease using smartphone technology or virtual doctor visits from home in order to overcome limitations of traditional clinical trials, and thereby accelerate development of improved treatments for people with Parkinson's.